Brief Suicide Intervention for Youth in Juvenile Detention Settings

Youth with juvenile justice involvement are at markedly increased risk for suicidal ideation, suicidal behavior
and death, and non-suicidal self-injury (NSSI) (Gallagher & Dobrin, 2006; Stokes et al., 2015). Much of this
suicidal and self-harm behavior occurs in the context of psychiatric and substance use problems and histories
of adverse life experiences (e.g., Charak et al., 2019; McNair et al., 2019; Teplin et al., 2015). The rates of
mental health disorders and suicide risk increase with more restrictive environments, including juvenile
detention facilities (Hayes, 2005; Stokes et al., 2015; Wasserman, et.al., 2010). Given the increased risk of
detained youth, the purpose of this study, responsive to NIMH PAR 18-228, “Pilot Studies to Detect and
Prevent Suicidal Behavior, Ideation, and Self-Harm in Youth in Contact with the Juvenile Justice System,” is to
develop, refine, and preliminarily test a trauma-informed, strengths-based, developmentally appropriate brief
intervention for staff in short-term detention facilities responding to detained adolescents’ suicidal ideation and
behavior, and NSSI. It is our expectation that this brief intervention will provide support to detained youth
through cognitive-behavioral and dialectical behavior therapy strategies focused on increasing youth safety,
self-efficacy, reasons for living, and radical acceptance of their current life circumstances. The intervention will
be designed to help staff more effectively assess and respond to youth suicidal thoughts and behaviors, and
NSSI, resulting in more effective management of youth crises. The intervention will complement and build upon
existing resources and assessment and monitoring protocols within the juvenile detention setting. In particular,
the intervention will be designed to be delivered on- site at detention facilities by existing detention staff who
work with detained youth. The first aim of the project is to develop and refine standard procedures for the new
intervention for suicidal youths in crises in juvenile detention. The second aim is to develop procedures for
training detention staff members who will provide this intervention to detained youth. In the context of an open
trial (n=20), the third aim is to assess the feasibility of this intervention, and to use experiences from
implementing the intervention and feedback from detention staff and youth to refine the intervention. The last
aim is to obtain, in a pilot randomized controlled trial (n=200), preliminary data regarding the feasibility and
acceptability of the intervention, as well as the impact of the intervention on suicidal thoughts and behavior,
NSSI, emergency services, linkage to care after release, and presumed mechanisms of action. The proposed
research is intended to demonstrate the feasibility and potential utility of a model that can eventually impact
services delivery by detention staff for detained at-risk youth, resulting in improved outcomes. The results of
this study will inform the development of a future larger scale hybrid implementation effectiveness trial.

Public health relevance
Youth with juvenile justice involvement are at increased risk for suicidal thoughts and behavior, death by suicide, and non-suicidal self-injury (NSSI), but staff in short-term juvenile detention facilities often do not receive training for addressing this risk. In this project, an intervention is being developed (adapted from existing evidence-based approaches) to help detention staff respond to this risk. This intervention has the potential for reducing risk for suicidal thoughts and behaviors, and NSSI, and increasing linkages to care following discharge among a particularly high risk group of youth.